Project 2 -- MIDUS Daily Diary Project

ABSTRACT – DAILY DIARY PROJECT
The objective of the MIDUS Daily Project is to determine how short term fluctuations in daily stress processes
impact longer-term health and well-being throughout midlife and later adulthood. Specific aims are to: (1)
Assess changes in multiple aspects of daily stressors and daily well-being across up to four occasions
spanning up to 30 years and three historic periods; (2) Investigate how disrupted diurnal rhythms of salivary
cortisol provide a physiological mechanism linking daily stress and health; and (3) Add tablet-based mobile
assessments of daily experiences to the MIDUS protocol to enhance daily measurements of stress processes
and capture unique assessments of cognitive health. These aims will be addressed by conducting additional
waves of longitudinal data collection for the MIDUS Core and Refresher Daily projects. We will continue to use
an 8-day telephone diary study of daily stressors and well-being combined with multiple assessments of saliva
(4 occasions × 4 days) to obtain salivary cortisol. In addition, we will add a 14-day tablet data collection
following the daily telephone survey. The MIDUS Daily project will continue to incorporate the rich
sociodemographic, personality, and cognitive measures from other MIDUS projects in our analyses to study
how they relate to changes in daily stress processes over up to 30 years. We will also use data from the gene
expression, biomarker, and neuroscience projects to examine how changes in daily stress processes predict
gene expression profiles and changes in various indicators of health (e.g., allostatic load, inflammatory
processes, neuroendocrine regulation, cardiovascular risk).